Core E - ORE Core

Mount Sinai ADRC (Sano): Outreach, Recruitment and Engagement Core (Core E) – Research Summary
The overarching goals of the Outreach, Recruitment and Engagement Core are to provide targeted
outreach to a culturally, racially, economically and cognitively diverse group of older community members to
ensure recruitment and retention for investigators in the ISMMS-ADRC and allied collaborators. Our activities
are well-integrated with the other Cores and our accomplishments have been achieved through close
collaboration with other departments at the Mount Sinai Health System (MSHS), and a number of community
organizations including the CaringKind, the Alzheimer’s Association, Project Linkage, and Union Settlement.
We will be focusing our attentions on community gatekeepers, as well as on exploring barriers to blood draws
and imaging and developing outreach materials to address this. New collaborations will include solidifying and
expanding our relationships with Black/African American senior centers in Central Harlem.
Our registry will become two tiered – one (“Center Interested”) which will serve primarily as an
information portal and to maintain engagement with the broader community, and a smaller one within it (“Trial
Interested”) which will be focused directly on bringing people into available clinical trials and studies. The Core
will disseminate information widely and explain new knowledge to professionals, trainees and the lay public.
We will continue our successful programs like the Virtual Lunch talk Series and support interdisciplinary
hybrid/webinars featuring basic, translational and clinical talks. For the community we will providing outreach
programs in English and Spanish, new written and web-based information, broadened social media presence,
and community events that publicize the latest developments in dementia research. The Core will continue to
work closely with our CAB made up of older diverse community members, to identify research priorities,
address barriers, and guide the development of recruitment strategies. With training and support, the CAB will
partner with the Core to co-present at senior centers as knowledgeable peers. Retention and engagement will
be fostered through expanding our successful programs (e.g. ADRC Virtual Lunch Series, and the Newsletter),
continue the important caregiver support by our social worker, and expanding our registry retention with new
staff engaging our participants. Needs analyses and assessment of the return on our recruitment and outreach
investments and surveys and interviews will help modify programs and guide future projects. Outcomes will be
evaluated through feedback forms, surveys, questionnaires, and pre-post tests and results will be used to
modify and plan future efforts.